CORE--DATA ANALYSIS AND ACQUISITION

The specific aims of the core are to provide statistical design services, to design forms, conduct interviews, enter, verify, and manage data, perform statistical analysis, and develop and/or standardize measurement instruments that are needed by the MAMDC.